Clinical Imaging Performance Evaluation of a Multi-Knife-Edge Slit Collimator-based Prompt Gamma Ray Imaging System

Project Summary
Proton therapy’s intrinsic advantage over conventional radiotherapy is the ability to selectively deposit large
amounts of dose within a primary tumor site or region of interest while minimizing dose to healthy tissue. To fully
leverage this advantage, proton range must be precisely controlled, monitored, and verified. Small errors in
particle delivery can result in significant dose delivered to healthy tissue and more importantly minimal dose
delivered to target volume. However, there is a lack of clinical solutions for proton range verification. Current
approaches employ either positron emission tomography (PET)-based or prompt gamma imaging (PGI)-based
techniques, which exploit the secondary emissions from charge particle tracks. PET is enabled for proton range
verification due to positron emitting nuclei created in the charge particle tracks. Unfortunately, radionuclides of
interest for this technique can have a half-life as long as 20 minutes, wherein significant biological washout can
occur, degrading the correlation between annihilation photon origin and the original proton track location. PGI
presents the most promising opportunity for real-time, in vivo range verification for charge particle therapies, as
the secondary emissions in this approach are produced on very short time scales (picoseconds-to-milliseconds).
To address the need for a clinical in vivo range verification system, Lawrence Berkeley National Laboratory
(LBNL) has developed a prototype imaging system based on a novel multi-knife-edge slit collimator for high
energy gamma-rays in combination with pixelated scintillation detector readout. This prototype provides two-
dimensional imaging of PGI tracks using this collimator. Preliminary evaluations of the imager with 50 MeV proton
beams showed exceptional promise for imaging proton tracks via their prompt gamma emissions, including sub-
mm precision for proton range quantification with proton statistics commensurate to those present during
therapy. We propose to evaluate this prototype PGI system in clinically relevant beam energies, beam currents,
and scenarios to demonstrate its performance capabilities in a clinical setting. Data from these evaluations will
fully characterize the prototype system’s capabilities, highlight clinical utility, and also guide the design of an
advanced clinical imaging system for real-time, in vivo proton range verification in a small modular platform that
can be positioned about the patient and gantry for any treatment regimen.

Public health relevance
Project Narrative We propose to evaluate a prompt gamma imaging system for in vivo particle range verification in clinical therapy beams and scenarios. The system leverages a novel collimator design for high energy gamma rays along with segmented, fast scintillation detectors to create two-dimensional, time-correlated images of secondary emissions from charge particle tracks. Successful implementation of this novel clinical imaging system will provide accurate, real-time range verification in proton therapy, which is key to realizing the utility of sharp dose profiles available, compared to conventional radiotherapy.